Elucidating Neural Mechanisms and Sex Differences in Response to Mindfulness Based Stress Reduction in Generalized Anxiety Disorder

PROJECT SUMMARY/ABSTRACT
Mindfulness-Based Stress Reduction (MBSR) has demonstrated efficacy for Generalized Anxiety Disorder
(GAD), yet there remains a major knowledge gap about its neural mechanisms. Neuroimaging studies thus far
have mostly focused on the impact of MBSR on structural and resting-state brain changes, and these studies
have been predominantly conducted in healthy participants. Core features of GAD, such as ruminative worry,
represent dysfunctional emotion regulation strategies that increase bias towards future threat. MBSR success is
associated with improved emotion regulation, enhanced attention to the present moment, and non-judgmental
acceptance of internal and external cues. Our primary aim is to elucidate neural mechanisms that drive response
to MBSR in patients with generalized anxiety disorder (GAD), and to examine the degree to which sex differences
in MBSR response are explained by sex differences in these mechanisms. Our overarching hypothesis is that
MBSR enhances ‘top-down’ learning and memory capacities that are broad and impact ‘top-down’ as well as
‘instinctual’ abilities (bottom-up) to regulate fear and emotions. We will first study the functional activation of brain
regions associated with the fear extinction network (ventromedial prefrontal cortex (vmPFC), hippocampus, and
amygdala) as a specific probe of the ‘instinctual’ type of emotion regulation. Second, we will use a novel analytic
approach to examine large-scale functional connectivity as a marker of neural plasticity changes (pre- and post-
MBSR) trial-by-trial during fear extinction learning across the entire brain, focusing analyses on the default mode
network (DMN), frontoparietal network (FPN), and ventral attention network (VAN). Next, we will examine sex
differences in MBSR-induced neural changes and their relationship to sex differences in clinical GAD response.
Finally, we will use a novel statistical approach to explore whether baseline neural measures can predict MBSR-
induced neural changes and clinical symptom reduction to identify likely MBSR responders. Participants will
undergo a standardized 2-day fear conditioning and extinction paradigm in the fMRI scanner before and after
MBSR or stress education (SE) with primary clinical outcomes at endpoint and 3 month follow-up. This study’s
objectives are aligned with NCCIH’s PA-18-323: Fundamental Science Research on Mind and Body Approaches
by studying MBSR’s neural mechanism of action and sex differences in patients with generalized anxiety disorder
(GAD), a prevalent condition often seen in primary care for whom MBSR efficacy is established. This study will
deploy rigorous scientific methods with a time and attention control intervention to enable isolation of MBSR’s
mechanistic impact on brain regions involved in emotion regulation and clinical response. The unique
combination of a focus on a classic anxiety condition with established emotion regulation difficulties implicating
target neural circuits, previously demonstrated MBSR efficacy, and sex differences with rigorous fMRI behavioral
probes with novel analytic approaches ought to provide major new insights about MBSR mechanisms and sex
considerations, moving towards precision medicine that could guide future treatment development research.

Public health relevance
PROJECT NARRATIVE Despite demonstrated clinical effectiveness of Mindfulness-Based Stress Reduction (MBSR) for anxiety, there remains a gap in knowledge about the brain mechanisms by which MBSR works and the neurobiological mechanism for sex differences in MBSR response for the common condition of Generalized Anxiety Disorder (GAD). GAD is an example of a condition with perturbations in these relevant emotion regulation and attentional neural circuits for whom MBSR has demonstrated efficacy. Building on prior data supporting our hypotheses about MBSR, GAD, and sex differences in fear and extinction neurocircuitry as well as novel whole brain functional connectivity analyses, we propose a rigorous neuroimaging study to examine how MBSR works, focusing on MBSR induced neural mechanisms that drive response to MBSR in patients with generalized anxiety disorder (GAD), and the degree to which sex differences in MBSR response are explained by sex differences in these mechanisms, in line with moving mind body interventions for common problems such as GAD towards precision medicine.